PEURTO RICO BIOINFORMATICS WORKSHOP (APRIL 27-MAY1 2009)

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. A two day bioinformatics workshop at Catolica in Ponce and Metropolatana in San Juan.